Engagement Core

PROJECT SUMMARY/ABSTRACT
Engagement Core
The Engagement Core serves as the central engagement, translation and dissemination, and training
component of the proposed Learning Disabilities Research Center (LDRC), Learning Disabilities Translational
Science Collective: Building on the Florida LDRC. To support this broad objective, the Engagement Core has
three specific aims guided by research evidence on bidirectional research engagement (Specific Aim 1),
translation and dissemination of research findings (Specific Aim 2), and structured project-embedded research
career enhancement efforts for early career scholars and community members (Specific Aim 3). The
Engagement Core will be housed at the Florida Center for Reading Research (FCRR) at Florida State
University (FSU). FCRR will serve as the base for the core’s main administration and activities. The
Engagement Core will collaborate with the Administrative Core, Data Management Core, and Project Leads to
accomplish these specific aims.